Atrioventricular Block Elimination by Rozanolixizumab Treatment

Abstract
Selectively targeting IgG recycling at the maternal-fetal interface to reduce pathogenic IgG by inhibition of the
fetal neonatal Fc gamma receptor (FcRn) and acceleration of IgG destruction, carries the potential to eradicate
autoantibody mediated diseases affirming the prediction “no antibody, no disease.” The nearly invariant finding
of high titer autoantibodies reactive with SSA/Ro52kD and 60kD ribonucleoproteins in pregnancies complicated
by cardiac neonatal lupus (cardiac-NL), strongly implicates these autoantibodies as required for the development
of disease. Maternal IgG accessibility to the fetal circulation is mediated by binding to syncytiotrophoblast
expressed FcRn. Importantly, we recently demonstrated anti-SSA/Ro52kD and 60kD in cord blood and serosal
cavities from 3 midtrimester fetuses dying with cardiac-NL, proving very early transplacental passage. The
signature cardiac disease, detected in the midtrimester, is irreversible 3° atrioventricular block with extensive
endocardial fibroelastosis, valvular dysfunction, and cardiomyopathy in some cases. Cardiac-NL is fatal in nearly
20%, requires life-long pacing in survivors, and can result in cardiac dysfunction by early adulthood in 30%. The
risk in fetuses exposed to high titer anti-SSA/Ro autoantibodies with no prior affected siblings approaches 4%
as supported by the ongoing Surveillance and Treatment tO Prevent AV Block Likely to Occur Quickly (STOP
BLOQ) trial. Our group has shown that hydroxychloroquine (HCQ) reduces cardiac-NL recurrence from an
historic benchmark of 18% to 8%. Accordingly, the development of monoclonal antibodies that block FcRn,
recently shown safe and effective in fetal hemolytic disease, presents an unprecedented preventative strategy.
Driven by the rationale that cardiac-NL will be thwarted by a dual mechanism of action, lowering maternal anti-
SSA/Ro autoantibodies and blocking placental transport, we propose AVERT (Atrioventricular block Elimination
by Rozanolixizumab Treatment) led by STOP BLOQ mPIs, Jill Buyon (rheumatologist, immunologist) and Bettina
Cuneo (fetal cardiologist) complemented by Justin Brandt (maternal fetal medicine). Rozanolixizumab (roza) is
an FcRn blocker FDA approved for myasthenia gravis. In Aim 1, an open label prospective single arm study of
pregnant subjects with high titer anti-SSA/Ro and a previous cardiac-NL offspring will address whether roza
10mg/kg weekly from 14-25 weeks plus HCQ will significantly reduce the recurrence rate. Limiting study drug to
before and during the vulnerable period for cardiac-NL should decrease the need for maternal or neonatal IVIG
rescue. A very low recurrence rate of 2% is expected and will be compared to 8% (HCQ alone) with 80% power,
Type I error rate of 5%. The first stage of this Simon’s 2 stage design will enroll 35 patients with termination due
to inefficacy if ≥ 2 cardiac-NL occur out of 35. Stage 2 will recruit 54 additional patients; the drug will be
considered efficacious if < 4/89 develop cardiac-NL. In Aim 2, timing and durability of anti-SSA/Ro52kD and
60kD will be evaluated following treatment with roza. Aim 3 will determine fetal, neonatal and maternal safety of
roza. Positive results may set precedent for universal anti-SSA/Ro testing in pregnancy.

Public health relevance
NARRATIVE Although the use of hydroxychloroquine has reduced the rate of recurrent anti-SSA/Ro-associated permanent fetal complete (i.e., 3°) atrioventricular block (AVB) identified in the midtrimester, 8% of women with a previously affected child face yet another pregnancy complicated by this potentially fatal disease. A novel therapy, rozanolixizumab, a biologic agent designed to decrease the maternal circulating levels of anti-SSA/Ro autoantibodies and inhibit placental transfer to the fetus, will be tested in pregnant women who have had a previously affected child with AVB with the goal to significantly improve the efficacy of hydroxychloroquine or fully avert disease. The impact of this work is high, since a positive result could change the management of all women known to have high titer anti-SSA/Ro antibodies and justify testing every woman for these antibodies, even if they are asymptomatic, as part of an early pregnancy screen.